MyomiR-499, Exosomes and Endothelial and Endothelial Progenitor Cells dysfunction in Diabetes

PROJECT SUMMARY/ABSTRACT
Diabetes mellitus is a common chronic metabolic disease imposing great social and economic burden,
and is considered as one of the major health-threats in USA and worldwide. The morbidity of critical limb
ischemia (CLI) in diabetic patients is extremely high (up to 76% in some studies). Therefore,
understanding the mechanisms of CLI pathogenesis in diabetes is critical for developing novel
therapeutic strategies. We and others have reported that enhancing endothelial cell (EC) and endothelial
progenitor cell function improves ischemic tissue repair. Recently, there is growing evidence indicating
that diabetes severely impairs angiogenic property of EC/EPC that may directly limit CLI repair. The
overall goal of this proposal is to elucidate the role of muscle-specific miR-499 in diabetes-impaired
EC/EPC function. The premise of our proposed studies is based on our preliminary studies showing that
expression of miR-499, a muscle-specific miR, was enhanced in EC/EPCs from db/db mice. Our central
hypothesis is that diabetes e nhanced miR-499 impairs EC/EPCs function and ischemic limb repair
via skeletal muscle-derived exosomal delivery of miR-499 to EC/EPCs. We propose to conduct
complementary experiments organized under the following 3 aims: 1. Determine the role of miR-499 in
diabetes-induced EC and EPC dysfunction; 2. Demonstrate the role of muscle-derived
exosomes in miR-499-induced EC dysfunction in diabetes; 3. Elucidate the molecular signaling
downstream of miR-499 involved in diabetes-impaired angiogenic property of EC. Our findings will
provide fundamental insights into development of novel strategies for therapeutics of CLI in diabetic
patients.
1

Public health relevance
PROJECT NARRATIVE In spite of extensive approaches, critical limb ischemia (CLI) is still one of the leading causes of disability and mortality in diabetic patients in USA. In this proposal, we will investigate whether enhanced muscle-specific miR- 499, which has been considered as a marker of ischemic tissue injury in human, and its downstream signaling targets can modulate endothelial/endothelial progenitor cell-mediated ischemic limb repair in diabetes. The results of this proposal will therefore be highly relevant for improving public health and improving the length and quality of life of millions of diabetic patients.